Paper-based high shear hemostatic analytical device

PROJECT SUMMARY/ABSTRACT
There are many diseases (e.g. arrhythmias, coronary artery disease, and infections) and situations (e.g.
medical devices, trauma, and surgery) that require rapid and accurate point-of-care hemostatic tests,
especially when regulating antithrombotics or after a blood transfusion. However, there are few options
in resource-limited environments like low- and middle-income countries (LMICs), rural clinics, combat
environments, and many others. This is because current hemostatic assays require electrical power,
capital expense, skilled technicians, large equipment, and can be slow. As cardiovascular disease
increases in LMICs, there is an urgent need to provide innovative tools for these lower resource
environments. As an alternative, microfluidic-paper based analytical devices (PAD)s have been
developed for low resource settings as a point-of-care technology since these are rapid, cost-effective,
portable, disposable, eas-to-use, and typically require electricity. Such devices include the rapid antigen
tests developed for COVID-19, which provide critical rapid feedback for making educated health
decisions. These can be used almost anywhere with relatively little skill. Our goal is to develop a similar
point-of-care tool that we call the Paper-based Clotting Analysis Test (P-CAT). Current PADs are
limited for hemostatic analysis since they typically produce low flow conditions that can’t test many of
the processes/pathways in primary hemostasis. We have developed a fast-flow PAD that will be
incorporated into the P-CAT, enabling us to investigate the spectrum of pathways involved in
hemostasis with only a drop (microliters) of blood. P-CATs can be created rapidly and at very little cost,
thereby producing high throughput data. Here, we will develop the P-CAT to test blood samples with
high specificity and and sensitivity to 1) pathways in primary (platelet-dependent) hemostasis, and 2)
intrinsic and extrinsic coagulation cascades in secondary hemostasis. If successful, we will expand
upon the P-CAT to incorporate additional biomarkers in an automated point-of-care device that could
have a major impact on enabling portable, rapid, and inexpensive tests for hemostasis that can be
widely distributed.

Public health relevance
PROJECT NARRATIVE Bleeding or excessive blood clots are concerns in multiple diseases, injury, and in many other situations that require blood thinners/anticoagulants. It is difficult to manage these conditions in limited-resource settings, especially since current tools to test blood are expensive, cumbersome, and slow. To overcome these drawbacks, we will create a low cost, highly portable, accurate paper-based clotting analysis test (P-CAT) to assess characteristics of blood clotting, while requiring no external power, similar in concept to rapid antigen tests used for COVID-19.